RESPIRATORY SINUS ARRHYTHMIA IN TERM AND PRE-TERM INFANTS

A study to establish normative data for Respiratory Sinus Arrhythmia (RSA) by special analysis to answer how gestational age and respiratory rate affects RSA.